SF Bay Area MACS/WIHS Combined Cohort Study

Project Summary
The MACS and WIHS are major studies of the long-term natural and treated history of HIV infection in the
U.S. The San Francisco Clinical Research Site (SF CRS) proposes to make vital contributions to the
MACS/WIHS Combined Cohort Study (MWCCS) scientific agenda through the recruitment and retention of a
diverse group of women and men whom are representative of the HIV epidemic in our region (i.e., racially
and ethnically diverse, sub-optimal engagement in care); continued scientific leadership of MWCCS including
strong mentoring of early career investigators who work with MWCCS; and consistent participation in
MWCCS studies. To enroll and retain both men and women with and at risk for HIV consistent with MWCCS
targets, we will continue a strategy of multisource recruiting that supports enrollment of participants who
represent cases and controls in the local community. We will continue to provide MWCCS scientific and
structural leadership by unifying the MACS and WIHS in collaboration with the data analysis and
coordination center and the MWCCS Executive Committee, leading new MWCCS integrated scientific
working groups, and supporting early career investigators through the collaborative engagement of a large
core of senior SF CRS investigators (five with K24 awards) who have outstanding mentorship skills, with the
goal of developing a new generation of skilled translational scientists. The SF CRS will provide leadership in
several domains of vital importance to the MWCCS scientific agenda including HIV pathogenesis,
neurocognitive impairment and brain structure/function, genomics, cardiac electrophysiology, pharmacology,
informatics, and comorbidities. Specifically, we propose to: 1) contribute to the understanding of the HIV
reservoir through deep phenotyping of leukocyte populations in peripheral blood, gut tissue, endocervical and
seminal cells; 2) examine the relationship of HIV and gonadal aging on deficits in neurocognitive functioning;
3) pursue novel electrocardiographic studies to evaluate subclinical cardiac and neurocognitive injury in
PLWH; 4) leverage linked studies to better understand inter-relationships of multiple morbidities (e.g., cardiac,
peripheral vascular, hepatic, renal, pulmonary, neurocognitive, physical function; and 5) lead genomic (e.g.,
genetic, epigenetic, mitochondrial) discovery efforts on the outcomes evaluated in the MWCCS.

Public health relevance
Project Narrative The MACS and WIHS are major studies of the progression of HIV infection in men and women who are representative of the epidemic (e.g., racially and ethnically diverse, variable degrees of engagement in care) in the United States. The goal of the newly merged cohort is to study the “health span” of people living with HIV now. The relevance of the proposed research would be to contribute fundamental knowledge on the impact of factors (i.e., sex, race and ethnicity, somatic and gonadal aging, psychosocial, genetic) on HIV progression and risk for comorbid conditions (i.e., cardiovascular disease, cancer, neurocognitive impairment, and lung, kidney, liver and physical function changes).